Administrative Core

Project Summary – Burkina Faso ICEMR Administrative Core
The Administrative Core of the Burkina Faso ICEMR will provide the organizational capacity across ICEMR
institutions and to the entire project for completing our goal of defining the spatiotemporal heterogeneity of
malaria and malaria transmission, including both parasites and vectors, across the Sahelian, Sudano-Sahelian,
Sudanian ecozones of Burkina Faso and within differing landscape environments (urban, rural, and
migrant/artisanal gold-mining camps). The Administrative Core will be based at CSU and led by PD/PI Foy,
who will closely coordinate with the PD/PIs and Lead investigators at Yale, IRSS and INSTech to plan and
direct all elements of the entire project. The lead ICEMR Administrative Core manager will also be based at
CSU, who will direct all administrative activities, approvals, budgets, communications and planning, and
lead/advise similar managers at the IRSS and INSTech, as well as their accountants. It will be supported by
administrative, grants management and accounting staff at CSU’s Department of Microbiology, Immunology
and Pathology, and Office of Sponsored Programs. The Administrative Core will work to build a cohesive and
complementary team among our institutions, researchers and country partners, build capacity at partner
institutions in Burkina Faso, provide effective and efficient management of the ICEMR budget and
subcontracts, coordinate and integrate the sharing of ideas, science and technology among all partners, and
facilitate the communications of all ICEMR functions, presentations and publications.